Time-lapse epigenome profiling in support of next generation cellular reprogramming

Project Summary/Abstract
Early human development generates thousands of precise cell fates from a single zygote with extreme fidelity.
This is largely accomplished via the coordinated regulation of gene expression in cell type- specific patterns.
Extensive observation of these patterns has nominated candidate genes that can be exogenously expressed
in non-target originating cell types to generate desired cell types through a process called cellular
reprogramming. For instance, the overexpression of defined transcription factors (TFs) in human fibroblasts
can be convert them directly into a variety of therapeutically useful cell types, including neurons and
cardiomyocytes. However, most reprogramming schemes produce heterogeneously differentiated cells that
do not faithfully adopt the gene regulatory programs of the target cell types, and consequently are unsuited for
therapeutic applications. It is increasingly appreciated that epigenetic factors, including the structure and
composition of chromatin, might influence the efficiency of reprogramming in a given cell. For instance,
nucleosomal wrapping of DNA and compaction in heterochromatin can silence natively active genes to
promote cell type conversion. Therefore, epigenetic events represent unobserved variables that can confer
differential competence for reprogramming. Here we propose to observe these variables directly using a novel
time-lapse epigenome profiling method, in which multiple snapshots of heterochromatin protein enrichment
and how they change over time are captured in the same single cells. We will use time-lapse information to
identify key spatiotemporal changes in chromatin-mediatedgene regulation that are associated with successful
reprogramming and use catalytically inactivated Cas9 fused to chromatin regulatory domains to functionally
test whether these events can lead to more efficient iEP outcomes. We further will produce rich, standardized
datasets from time-lapse profiling of common reprogramming trajectories for public use, with a focus on their
utility for deep learning approaches to discover new modulators of reprogramming efficiency In the long term,
we anticipate that these improved methods we introduce will improve the rational design of efficient cell type
conversion schemes for tissue regeneration and other important therapeutic purposes.

Public health relevance
Project Narrative The ability to deliberately design human cells and tissues could revolutionize regenerative medicine, but current approaches for doing so are plagued by inefficiency. This project seeks to design new tools for precisely observing how epigenetic events lead to successful cell type conversion outcomes, so that we can more efficiently create cell types of interest.